Training in Sleep and Sleep Disorders

? DESCRIPTION (provided by applicant): This proposal is for a training program in the area of sleep and its disorders. There is growing evidence of the prevalence of sleep disorders in the American population, and that problems related to inadequate sleep have a major impact on many aspects of our society. At a basic level, little is known about the fundamental mechanisms that control sleep and the function(s) of sleep. Thus, there is a major opportunity for scientific discovery. One of the barriers that is recognized to advancing the knowledge base in this area is the paucity of investigators, both those engaged in basic research and in patient-oriented research. This application describes a training program that is based on the relatively unique faculty resources and structure at the University of Pennsylvania for support of research in sleep and its disorders (the Center for Sleep and Circadian Neurobiology). The proposal describes four specific training aspects that are intended to complete the matrix for training opportunities at the University of Pennsylvania in the area of research in sleep/sleep disorders. These four aspects are the following: a) a 5-year graduate program in neurobiology of sleep and circadian rhythm. This will be based on the highly successful and well developed Neuroscience Graduate Program. We will utilize, where appropriate, structures, courses and other resources developed by this group; b) a 5-year graduate track in genomics/computational biology; c) a targeted MD/PhD program to train physician-scientists in sleep research (this component is 5 years). This aspect of our program will be based on the outstanding institutional MD/PhD program at the University of Pennsylvania; and d) a 2-year postdoctoral training program for nurse investigators. This will be based on the preeminent School of Nursing at the University of Pennsylvania. The strong, well-established collaboration between the Sleep Center and the School of Nursing provides a unique opportunity to develop a much needed national program to train nurse investigators in this area. All of these components of the program will utilize the extensive resources for research that have been developed by the Center for Sleep and Circadian Neurobiology at the University of Pennsylvania.

Public health relevance
PROJECT NARRATIVE The goal of this program is to train graduate students, physician-scientists and postdoctoral nursing fellows to conduct research in sleep and its disorders.